Disulfiram for Entameoba histolytica Enteric Diarrhea [DEED] Trial

PROJECT SUMMARY/ABSTRACT
This proposal is in response to PAR-20-270, whose funding purpose is to support the planning
of a future trial. Protozoan parasites pose significant global health burden, yet therapies are
limited and new drug discovery remains costly. Drug repurposing can drastically cut these costs
by rapidly finding new indications for existing drugs. For example, amebiasis, caused by
Entamoeba histolytica, is a leading cause of severe diarrhea and death from parasitic infection
worldwide. Globalization, immigration, travel to and from endemic areas, and sexual practices
are contributing to re-emergence in developed countries.The work is significant because
amebiasis treatment options are inadequate relying on only one drug class. Therefore, we are
not prepared for intolerable side effects or emerging drug resistance, which is a real concern
and there are no alternatives. Hence, identification of new anti-parasitic drugs is priority. We
found that zinc ditiocarb, a metabolite of the inexpensive, globally available, oral FDA-approved
drug disulfiram, was 1000-fold more potent than metronidazole and was an effective anti-
amebic agent in pre-clinical animal studies of amebic colitis. Zinc ditiocarb is safely given as
disulfiram plus nutritional zinc supplement. We propose to test the hypothesis that oral
disulfiram plus zinc supplement effectively treats Entamoeba histolytica diarrhea. Our proposed
approach, the Disulfiram for Entamoeba histolytica Enteric Diarrhea (DEED) Trial is an
international phase 2a, double-blind, randomized control trial of patients with symptomatic
diarrhea due to E. histolytica. If our hypothesis holds true, the proposed trial could result in an
innovative repurposed indication for the first new drug treatment for amebiasis in over 60 years.
Also of significance, zinc ditiocarb may prove to be a novel broad-spectrum anti-parasitic agent
for other difficult-to-treat parasites such as Leishmania and Trypanosoma, as in vitro efficacy
against these parasites has also been shown. This R34 planning grant will allow completion of
the critical planning, rigorous design and essential preparation of the documents needed to
ensure the successful conduct of the DEED trial.

Public health relevance
NARRATIVE Amebiasis is a major cause of morbidity and mortality worldwide and recent trends have shown re-emergence in developed countries due to travel to endemic areas, immigration, and sexual transmission, placing us all at risk. There is only one drug class available for treatment, which is a major public health concern as we are left with no option if resistance or intolerable side effects develop. Treatment options for parasitic infections remain limited and if successful the DEED trial could lead to the first new amebiasis drug in 60 years and ultimately lead to clinical use against other difficult-to-treat parasites.